Core-002

The Community Engagement and Collaboration Core (CECC) supports the UMass Center for Clinical and Translational Science’s (UMCCTS) overarching vision of creating a robust and transformative clinical and translational research and education enterprise across the 5 UMass campuses by leading programs and services and conducting educational activities that facilitate the integration of community engagement and team science approaches in translational research endeavors. Community engagement and team science are central, guiding tenets to all UMCCTS Core activities and programs, and support the CTSA goal of responding to unmet health needs with efficient, effective, high-quality research that is relevant, practical, and valuable to the populations it serves. By supporting a culture of collaboration across disciplines, campuses, and communities, the UMCCTS drives innovation in research and education across the spectrum of clinical and translational research. We define community broadly to include all stakeholders with a vested interest in addressing the unmet health needs of our community. This includes members of our local communities and clinical, public health, and community-based providers/practitioners, organizations, and industry partners. We foster transdisciplinary collaborations across the 5 UMass campuses, leveraging unique strengths of each campus, and engage in CTSA consortium collaborations that advance the reach and impact of science. UMCCTS activities are founded on key principles of trust, respect, bi-directional communication and mobilization of community strengths and assets by fostering productive collaborative relationships that achieve mutually identified goals. The CECC has been highly productive in supporting teams from across the 5 UMass campuses. Our programs and services have been integrated throughout our UMCCTS Cores. Our Specific Aims build upon these successes and incorporate lessons learned. Guided by the UMCCTS Community Advisory Board (CAB), the CECC will lead activities that are vital resources for investigators and teams across the translational research spectrum, addressing pressing community-identified health priorities and advancing science. The CECC Specific Aims are to: (1) Further integrate principles and practices of collaboration and community engagement throughout UMCCTS activities to impact health; (2) Implement educational and workforce development programs and mentoring to promote transdisciplinary collaboration, team science, and community engagement across the UMCCTS; (3) Expand our Community-based Research Network (CBRN) as a means of enhancing the scale, scope, and impact of collaborative academic/community research, and (4) Contribute to the advancement of the science and practice of collaboration and community engagement across the CTSA hubs.

Public health relevance
The Community Engagement and Collaboration Core (CECC) supports the UMass Center for Clinical and Translational Science’s (UMCCTS) overarching vision of creating a robust and transformative clinical and translational research and education enterprise across the 5 UMass campuses by leading programs and services and conducting educational activities that facilitate the integration of community engagement and team science approaches in translational research endeavors.